ADAPTING AND ASSESSING THE FEASIBILITY OF A TELEHEALTH DIABETES PREVENTIONPROGRAM FOR HISPANIC ADOLESCENTS

Project Summary
Hispanic adolescents are disproportionately burdened by type 2 diabetes (T2D) and social determinants of health
(SDoH), which can serve as barriers to behavior change and participation in disease prevention efforts.
Telehealth is a potentially effective approach for delivering disease prevention programs in vulnerable
communities as it reduces the burden of some SDoH like transportation, childcare needs, and parent work
schedules. However, there are no theory- or evidence-based telehealth T2D prevention programs for Hispanic
youth. The goal of this career development award is to assist Dr. Erica Soltero in her long-term goal of becoming
an independent investigator designing and implementing T2D prevention interventions among high-risk pediatric
populations impacted by SDoH. Dr. Soltero’s short-term goals include gaining expertise in the use of mixed-
methods, the Self-Determination Theory (SDT), and development of technology-based interventions. In
collaboration with her multidisciplinary mentorship team, she has developed a training plan to reach these goals
via coursework, workshops, scientific meetings, and mentored research. The purpose of this study is to adapt
Everly Little Step Counts (ELSC), an evidence-based, culturally grounded T2D prevention program, for delivery
via telehealth and test the feasibility and acceptability of the adapted telehealth intervention. While telehealth is
more suited for remotely delivering nutrition education, other technology-based tools are needed to remotely
promote physical activity (PA). Thus, we will adapt and integrate our previously tested intervention that uses
activity trackers (i.e. Fitbit) and text-messages grounded in the SDT to promote PA into the telehealth program.
To ensure that all technology-based components are feasible and considerate of SDoH, we will use a mixed-
methods approach across three iterative phases to engage Hispanic adolescents (14-16 years; N=24) and their
parents (N=24) in the adaptation process. Once the ELSC-telehealth program is developed, a new sample of
Hispanic adolescents (14-16 years; N=40) with obesity (BMI%≥95th) will be recruited from community clinics
and randomized to the 12-week ELSC-telehealth intervention or usual care control group. Feasibility and
acceptability will be assessed using a priori feasibility criteria (e.g. recruitment, data collection, fidelity) and exit
interviews. We will examine the preliminary efficacy of the intervention on PA and T2D risk outcomes (fasting
glucose, insulin, insulin resistance and HbA1c). This proposal builds on the investigative team’s previous work
in T2D prevention, activity trackers, and text messaging to develop a telehealth delivered T2D prevention
program with great potential for reaching and engaging Hispanic youth. This study will advance the science on
telehealth as a disease-prevention tool among high-risk youth impacted by SDoH. Completion of the proposed
training and research will provide Dr. Soltero with the skills, research experience, professional development, and
scholarly products needed to apply for R01 funding and transition to a successful, independent scientist.

Public health relevance
PROJECT NARRATIVE Hispanic adolescents are disproportionately burdened by type 2 diabetes and social determinants of health that negatively impact health behaviors and contribute to the development of this costly disease. This study will adapt a 12-week, evidence-based, culturally-grounded diabetes prevention program for delivery via telehealth and will test the feasibility, acceptability, and preliminary efficacy of the telehealth intervention. This study will provide novel information on the use of telehealth to reach and engage high-risk youth from vulnerable, health disparate communities in disease prevention efforts.